Administrative and Clinical Acquisition Core

This core unit is located within the administrative offices at the Blood Research Institute, the research arm of the Blood Center of Wisconsin. The BRI includes the offices and laboratories of the research scientists of the institution, but also includes pediatric hematology faculty of the Department of Pediatrics at MCW, and is the location of the Comprehensive Center for Bleeding Disorders. This administrative core will coordinate this multifaceted program and consists of two major components.